The Experiences of Ethnic Minorities, and those with Liver Disease, during COVID-19, and The Impact on Related Health and Prevention Behaviors

The Experiences of Ethnic Minorities, and those with Liver Disease, during COVID-19,
and The Impact on Related Health and Prevention Behaviors
Chronic hepatitis B (CHB) infection affects up to 2.4 million people living in the U.S., and
disproportionately impacts people of Asian and African origin and Pacific Islanders, who also
face many challenges to healthcare access. People living with hepatitis B (PLHB) who represent
ethnic minorities also lack access to clinical trials; delaying their equitable access to innovative
medicinal products, blurring the true picture about the safety and effectiveness of such
products when used by these communities, and hindering the acceptability and uptake of such
products by members of ethnic minorities. Ultimately, this leads to major disparities and worse
health outcomes. PLHB and ethnic minorities were underrepresented in clinical trials for the
vaccine against SARS-CoV-2 (COVID-19). This has led PLHB to be concerned about how the
vaccine would affect their liver or health condition and has exposed an existing gap of lack of
dialogue between drug developers and community organizations representing PLHB and ethnic
minorities. The proposed study will help better understand the challenges and resulting health
behaviors (including COVID-19 vaccine uptake) among individuals from minority populations,
including PLHB, including an assessment of their access to credible and patient-centered
information on the safety of COVID-19 vaccines. The study proposes a mixed-methods
approach, collecting and analyzing data from PLHB and ethnic minorities, and their healthcare
providers, through one-on-one interviews and an online survey. The study also proposes
establishing an informed community advisory board (CAB) composed of PLHB who represent
ethnic populations most impacted by CHB. CAB members will be trained on topics related to
COVID-19, public health emergencies, and clinical trial participation. CAB members will cultivate
a sustainable dialogue with the drug development community, such as regulatory authorities
and drug developers, especially during times of public health emergencies. This study will
broaden our understanding of how ethnic minorities perceive newly approved medicinal
products, and ideas for improving future communication about these products. Study results
can be used to promote diversity and inclusion in clinical trials for COVID-19 vaccines and
therapeutics and newly developed products in other disease areas, and ensure that the benefits
of such trials reach the communities most in need, in the U.S. and globally.

Public health relevance
The Experiences of Ethnic Minorities, and those with Liver Disease, during COVID-19, and The Impact on Related Health and Prevention Behaviors This study will explore the COVID-19 related challenges and resulting health behaviors (including COVID- 19 vaccine uptake) among individuals from ethnic minority populations, and those living with hepatitis B. This includes an assessment of participants’ access to clinical trials and credible, patient-centered information on the safety of COVID-19 vaccines, perceptions of COVID-19 vaccines, and factors affecting their COVID-19 vaccine uptake. The results of this research will inform future drug development outreach efforts to ensure inclusion of patients’ voice in clinical trials’ design and conduct, and support regulatory decision making regarding inclusion of minority populations and people with liver disease in future clinical trials of COVID-19 vaccines and therapies.